The RCMI Program in Health Disparities Research at Meharry Medical College (Supplement)

AIDS disproportionately targets several minority groups, including the African American population. The burden
is due to the high frequency of HIV-1 infection rates and the high incidence of virologic failure of HIV antiretroviral
therapy, owing to the multidrug resistance in the African American population. To control the emergence of
multidrug-resistant HIV-1 and solve the AIDS Health Disparities issue, it is important to develop drugs against
novel viral targets. HIV-1 viral infectivity factor (Vif) is essential for virus replication. The primary function of Vif
is to counteract APOBEC3G (A3G), a potent host restriction factor for HIV. Vif-A3G interaction has been the
target for drug development. Accordingly, several groups have developed HTS assays to screen for small
molecules to inhibit Vif-mediated A3G degradation. However, none have advanced to clinical trials due to their
moderate potency in rescuing A3G antiviral function. Notably, there is evidence that Vif directly inhibits A3G
cytidine deaminase activity (CDA). Given that the efforts to identify effective inhibitors of Vif-mediated A3G
degradation have not been successful and A3G CDA is critical for its antiviral function, we will target Vif-mediated
A3G CDA inhibition function for identifying novel Vif inhibitors. To develop a chemical probe and lay the
foundation for discovering a new class of HIV drugs, we have established a novel and robust assay to screen
small molecules that target this function of Vif with excellent reproducibility and a calculated Z-score of 0.83. In
preliminary studies, we screened ~5500 compounds from a combination of several small compound libraries.
We obtained one hit, Quinobene, which showed potent antiviral activity (IC50:0.75-1.25 μM) by restoring A3G
function. The data validate our assay and support the hypothesis that screening a pharmacologically diverse
small molecule library can lead to the identification of Vif-specific inhibitors that target A3G CDA activity. In this
proposal, we propose to screen a collection of Natural Product Extracts (3K extracts, >30 compounds per extract,
totaling ~10K chemicals) in collaboration with Dr. Ashu Tripathi, Director of the Natural Products Discovery Core
at the University of Michigan (Aim 1). Natural Product Extracts (NPEs) with a high potency of inhibiting Vif
function will be selected for further validating the potency of Vif inhibitors and perform secondary assays to verify
their A3G-dependent anti-HIV activity in CD4+T cell lines (Aim 2). Finally, we will utilize the data-intensive
platform of Tripathi's lab to rapidly de-convolute identified hits to characterize active leads and biologically
characterize the promising leads in primary CD4+ T cells isolated from Caucasian and African American (AA)
populations (Aim 3). The proposed experiments will (i) develop chemical probes that can be used to elucidate
the function of Vif in counteracting A3G and (ii) lead to the discovery of potent anti-HIV inhibitors for the
development of new class antiviral drugs to address multidrug resistance issue disproportionately targeting AA
population.

Public health relevance
Human immunodeficiency virus type 1 and acquired immune deficiency syndrome (HIV/AIDS) continue to be global pandemics, with a recent estimate approximating 38.4 million cases of AIDS and 650,000 deaths in 2021. The goal of this proposal is to develop a new drug and provide more choices for people battling against AIDS and addressing multi-drug resistance disproportionately targeting African American population.